Mentored Patient Oriented Research in ARDS and Critical Illness Outcomes

PROJECT SUMMARY/ABSTRACT
The goal of this Midcareer Investigator Award in Patient Oriented Research is to provide key mentorship,
resources and protected time to strengthen Dr. Catherine Hough's success in mentoring students, post-
doctoral fellows and junior faculty in the science of patient-centered outcomes after the acute illness and injury,
with a focus on the acute respiratory distress syndrome and critical illness. Although hospital mortality after
critical illness has improved significantly over the past decades, there is increasing recognition that recovery is
incomplete, with a substantial burden of disability and impairments in function and health-related quality of life
among ICU survivors. Interventions to improve these patient-centered outcomes have been largely
unsuccessful, and understanding of the mechanisms of post-ICU impairments remains quite limited. Recently,
there has been increased recognition that pre-morbid health and disability are significant contributors to post-
ICU impairment and to the heterogeneous trajectories of recovery, but research and clinical practice have been
stalled by the difficulty of assessing pre-morbid factors at the time of ICU admission. Moving the field forward
will require innovative approaches to phenotyping patients using clinical data and techniques from clinical
epidemiology and health services research. Dr. Hough is an ideal candidate to provide mentorship in this area.
She is a mid-career investigator with expertise in observational and interventional studies of outcomes after
ARDS and critical illness, and she has a strong and growing track record in successful mentorship in patient-
oriented research as well as a strong existing research program. In this award, Dr. Hough will enhance and
advance her career in three ways. She will participate in structured activities to develop her mentoring skills,
including one-on-one sessions with Dr. Randy Curtis, local in-person workshops and national web-based
programs. She will gain content knowledge on muscle biology, use of computed tomography images in
assessing muscle mass and quality. Additionally, she will work with methods experts to learn to incorporate
clinical and administrative data of co-morbidity and health-care utilization into developing phenotypes of
premorbid disease that predict disability and recovery. The scientific goal of this project is to investigate the
relationship between premorbid muscle mass and quality, assessed via analysis of existing computed
tomography scans, and short and long-term outcomes after critical illness, including muscle strength, function
and disability. This project will leverage two ongoing R01-funded prospective cohorts for which Dr. Hough is a
PI which contain detailed assessment of co-morbidities and pre-morbid health care utilization, prospective
assessments of muscle strength and function during and after critical illness, and will create new opportunities
for mentored research. Dr. Hough's career development and scientific aims will provide an outstanding
environment for training of patient-oriented researchers focused on improving outcomes after critical illness.

Public health relevance
PROJECT SUMMARY/ABSTRACT Studies have shown that survivors of the acute respiratory distress syndrome and other critical illnesses commonly have impairments in physical function that are associated with disability and reduced health related quality of life. New strategies are needed to understand the contribution of premorbid disease and health status on recovery after critical illness in order to develop successful new treatments. This award will critically enhance the success of the principal investigator in training scientists in patient-oriented research by providing her with the needed mentoring, resources and protected time, which will contribute to advances in research and clinical care needed to improve patient-centered outcomes of patients with critical illness.